Statistical Methods In Epidemiology--general

This project develops new statistical methods for epidemiology with broad applications and also methods as needed for ongoing projects in epidemiology, particularly those related to large cohort studies and reproductive studies. The work this year involved two main projects. (1) We developed and applied an empirical Bayes approach for summarizing reproductive history for prediction of subsequent risk of the same complication or different outcomes; and (2) We are using data from the PRESTO study to compare the fits of models for time to pregnancy in order to select the best model for effects on fertility of folate supplementation during the attempt.